Strategic Health Concepts to conduct comprehensive communication services across the scientific programs and branches within the Division.

The Division of Cancer Control and Population Sciences (DCCPS) supports web-based, online, electronic and other communication and education efforts as part of its mission. These communication activities enable DCCPS to more effectively interact with stakeholders by sharing important information about the DCCPS research portfolios and the resulting tools, products, and scientific advances. These stakeholders include a wide range of constituents such as the extramural research and scientific community, NIH and Department leaders, scientific advisory boards, consumer liaisons, Congress, partner organizations within and outside government, cancer advocates, cancer survivors, and the general public.